Biomedical Research Vivarium

Project Summary/Abstract – Biomedical Research Vivarium
Animal models are extensively used by Boise State University investigators and are central to investigations of
cell-extracellular matrix interactions in pathophysiology of disease progression, wound repair, and tissue
regeneration. To foster a more sufficient and sustainable research environment, the Biomedical Research
Vivarium is dedicated to supporting investigators of the COBRE in Matrix Biology by providing essential
training, care, housing, regulatory oversight, production, preservation and sharing of mice, rats, and zebrafish
models in a timely and reliable manner. The vivarium will continue to support established investigators,
maintaining availability to all researchers for the duration of the grant funding period and beyond. The vivarium
represents a critical component of the research infrastructure that enhances current and future NIH-supported
research. Strengthening the vivarium will meet the needs of investigators and further, will allow expansion of
Boise State’s biomedical research capabilities. The vivarium has and will continue to enhance our biomedical
research training and education programs for graduate students by providing training in the responsible
conduct of research. The vivarium will also provide essential research infrastructure necessary for collaborative
research with nearby four-year colleges who do not have access to such facilities. A business plan to allow
sustainability will be based on a fee-for-service model. Additionally, the research culture shift that has occurred
at Boise State University during COBRE Phase I will support sustainability into the future as the vivarium works
toward AAALAC accreditation.